IGF::OT::IGF R&D Quality Control of Electronic Pathology (E-Path) results (Stage Appropriate Cases) Period of Performance 09/12/14 - 09/11/15

CPIC will assess quality and completeness of electronic pathology (E-Path) results for colorectal cancer and head and neck cancer. CPIC will collect electronic pathology results for KRAS mutation test results from colorectal cancer case records, and will collect human papilloma virus (HPV) results from head and neck cancer case records. CPIC will assess the completeness of these records and document compliance with recommended testing.